Visualization of Combinatorial Epigenetic Marks and Complexes in Animals Using Fl

DESCRIPTION (provided by applicant): Abstract Visualization of the epigenetic states of cells in complex tissues is important since many cell types cannot be cultured in vitro and since the epigenetic states of cells can change during isolation and culture. Many tissues are composed of heterogeneous cell types and differences in epigenetic states among superficially identical cells affect their developmental and pathological potentials. We propose to develop technologies that enable visualization of the epigenetic states of individual cells in complex tissues of living animals. Epigenetic states consist of combinations of molecular marks in conjunction with multiprotein complexes that act on those marks. The consequences of different combinations of epigenetic marks are determined by combinatorial mechanisms. The functions of epigenetic regulatory proteins are determined by the combinations of interaction partners that are present in complexes formed by these proteins. We propose to develop technologies that enable visualization of combinatorial epigenetic marks, chromatin binding by epigenetic regulatory proteins, and epigenetic regulatory complexes formed by different combinations of interaction partners in animals. The technologies for visualization of combinatorial epigenetic marks and of epigenetic regulatory protein complexes in animals are to be based on fluorescent protein fragment complementation. Fragments of fluorescent proteins can associate with each other to produce a fluorescent complex when they are tethered in molecular proximity to each other. Technologies based on this principle are well suited for imaging epigenetic states in animals because (1) the direct fluorescence read-out is robust under challenging imaging conditions in animal tissues, (2) the high spatial resolution enables analysis of subnuclear localization, and (3) the lack of fluorescence of the individual fluorescent protein fragments produces a high signal to background ratio.